Novel Antivirals Targeting Lenacapavir-Resistant HIV

Abstract
As of 2023, nearly 40 million people worldwide are living with human immunodeficiency virus (HIV), of which
over three-fourths have access to antiretroviral therapies (ARTs). Although access to therapies improves an
individual’s expected lifespan and quality of life, resistance-associated mutations (RAMs) can develop in the
virus in response to treatment. As a result, novel antivirals are needed to expand upon current options that are
available. Recently, the HIV capsid has become the newest FDA-approved antiviral target with the release of
Gilead Sciences’ lenacapavir (LEN), as the capsid is essential in both early and late stages of the viral replication
cycle. Unfortunately, administration of LEN – a picomolar-potency drug – has led to the early emergence of
RAMs that severely deplete the drug’s potency. To overcome the burden of LEN-resistant RAMs, novel capsid
effectors (CEs) have been developed by our laboratory in collaboration with a team of medicinal chemists. Three
of these CEs target the highly reported LEN-resistant mutant CAM66I (over 80,000-fold resistance) with higher
efficacy than LEN. I hypothesize that the unique structures of these novel CEs allow these compounds to work
against LEN-resistant CAs, including CAQ67H, CAN74D, and CAQ67H/N74D, distinctly from LEN. First, biochemical and
biophysical assessments of each CE•CA interaction will be done using biolayer interferometry, thermal shift
assays, CA Tube assembly assays, and native mass spectrometry (Aim 1). Additionally, the in cellulo potency
and cytotoxicity of each CE during infection with HIV – with and without these CA mutations – will be determined
using cell-based antiviral assays (Aim 2). Finally, insight into the structural differences owing to the CEs’ activities
will be provided by X-ray crystallography studies to solve high-resolution crystal structures of each CE•CA
complex (Aim 3). For all assays, comparisons will be made between WT and mutant CAs and between these
CEs and LEN to understand mechanistic differences among each CE•CA combination. Together, these three
aims will detail insight into methods of circumventing LEN resistance that can be used to optimize novel CEs
with potential to be used as ARTs. As a result, these studies will allow us to continue combatting drug-resistant
HIV through structure-based drug design, with the goal of suppressing the HIV epidemic.

Public health relevance
Project Narrative Nearly three-fourths of the 40 million people with human immunodeficiency virus (HIV) worldwide have access to anti-HIV therapies that target essential viral proteins, but mutations in HIV can develop during treatment that cause resistance to these antivirals. To combat the mounting burden of HIV resistance against lenacapavir (the newest FDA-approved HIV drug), I will use a multidisciplinary approach to determine how three promising compounds are able to target lenacapavir-resistant HIV. Ultimately, these studies can inspire the design of future therapeutics with the potential to treat lenacapavir-resistant HIV.